Definition and perturbation of cell-regulatory heterogeneities in solid tumors

ABSTRACT
Cell-state variation in cancer is important for tumor initiation–progression and creates a major hurdle to
effective anticancer therapeutics. Unbiased methods are needed to monitor single-cell regulatory states of
cancer cells in situ, as are approaches to analyze these data and generate actionable hypotheses about
cancer biology. This R50 Research Scientist application will support the activities of Dr. Lixin Wang, a 11-year
Research Scientist in the Unit directed by Dr. Kevin Janes, who is an expert in 10-cell transcriptomic profiling
by laser-capture microdissection (LCM). Dr. Wang is a co-developer of LCM-based 10-cell RNA sequencing
(10cRNA-seq; Sci Rep 2019) and is deeply involved in two NCI-sponsored projects (U01-CA215794 and R01-
CA214718) that stem from the technology. As the lead experimentalist for a U01 cooperative agreement
through the Cancer Systems Biology Consortium, Dr. Wang will perform molecular-genetic perturbations,
epigenomic studies, and in vivo tests of nucleocytoplasmic regulatory states that arise when breast epithelial
cells acutely activate the ERBB2 receptor tyrosine kinase. Dr. Wang will support the R01 research project on a
heterogeneously regulated tumor-suppressive ligand by training predoctoral students on 3D culture, molecular
cloning, intraductal xenografts, and regulatory compliance. In the past, Dr. Wang has collaborated effectively
with chemists and mouse geneticists at the University of Virginia (UVA) Cancer Center, all of whom strongly
support this R50 application. An R50 award would ensure successful completion of the U01–R01 aims and
enable Dr. Wang’s expertise to propagate more broadly within the NCI-supported research activity of the UVA
Cancer Center.

Public health relevance
PROJECT NARRATIVE Methods are available to measure all of the genes expressed by small numbers of cancer cells within tumors, but the approaches are very labor intensive and require considerable expertise. Dr. Wang has perfected and modernized these techniques over the past decade in the Unit directed by Dr. Kevin Janes to refine a skillset that is highly valued by the University of Virginia Cancer Center. R50 support will enable Dr. Wang to accelerate research progress within the Unit and collaborate to support additional cancer research on cancer- cell variability at the University of Virginia.